DNA PROBES OF THE HUMAN X AND Y CHROMOSOMES

Human sex reversal mutants (XX males, XY females) may be the result of gross anomalies of the X and Y chromosomes. To determine if this is the case, genomic DNAs from such sex-reversed individuals will be examined using a large number of DNA probes of the X and Y chromosomes. Should this line of inquiry lead to identification of a putative male-determining gene, that gene or its mouse homologue will, by means of a retroviral vector, be introduced into mouse embryos to test its ability to induce reversal of sex in vivo, potentially resulting in a highly defined mouse model for the study of abnormal sexual development. The above mentioned DNA probes of the X and Y chromosomes will be used to determine more precisely the nature and origin of certain numerical and structural anomalies of the sex chromosomes, all of which are associated with developmental and/or reproductive abnormalities. Regions of single-copy DNA sequence homology between the human X and Y chromosomes will be studied using DNA probes derived from these regions. The extent and exactness of X-Y homology will be quantitated and the evolutionary history of X-Y homology will be elucidated.